Tunneling Nanotube Inhibitors for Cancer Immunotherapy

ABSTRACT
In a recent study published in Nature Nanotechnology, we demonstrated that cancer cells form physical
nanoscales tentacles (nanotubes) to connect with and harvest mitochondria from immune cells. Such
mitochondria hijacking metabolically depleted the immune cells and augmented the cancer cells. These
findings have significant implications as it emerges as a novel mechanism of immune evasion by cancer
cells, which can limit the efficacy of immune checkpoint inhibitors. Here we propose to develop next-
generation immunotherapies that can perturb this novel immune evasion phenomenon. We are specifically
developing novel small molecule inhibitors of the exocyst complex, which we have implicated in the above
phenomenon. Our preliminary results show that such small molecules can exert a powerful antitumor
efficacy, augment classical immune checkpoint inhibitors and display an excellent safety profile. In Aim 1.
We will synthesize and characterize exocyst inhibitors in vitro to test the hypothesis that rationally designed
small molecule inhibitors of the exocyst complex can inhibit nanotube assembly. In Aim. 2. We will establish
the safety pharmacology of exocyst inhibitors in vivo. In Aim 3, we will test the hypothesis that exocyst
inhibitors can improve antitumor outcomes with immune checkpoint inhibitors. Achieving these aims will lead
to fundamental insights into a new mechanism of cancer-immune cell communication. Our preliminary
results indicate exocyst inhibitors can emerge as a new class of immunotherapy.

Public health relevance
SUMMARY Despite the promise of the immune checkpoint inhibitors, the outcomes with recently approved immunotherapies remain poor in many cancers. Less than 20% of patients treated with immune checkpoint inhibitors show durable response. This proposal studies a novel mechanism of immune evasion by nanotube-mediated mitochondria harvesting from immune cells by cancer cells, and will develop novel exocyst inhibitors that can overcome this barrier that limits immune checkpoint inhibitors.